Development of small molecule Protease-activated-receptor-2 antagonists as oral asthma therapeutics

Lay Abstract: Asthma is a widely prevalent condition that affects 1 in 12 adults in the United
States and an estimated 300 million individuals worldwide. Mild asthma is well controlled by
current standard of care (SOC), including long-acting b-adrenergic receptor agonists, anti-
leukotrienes and/or inhaled corticosteroids. As patients progress to severe disease add-on
treatment options can include newer biologics/antibody treatments. While these treatments are
useful for certain conditions, their application and known side effects limit their applicability
resulting in 50% of asthmatics remaining untreated. There is a clear need for developing novel
asthma drugs to treat this population. Protease-activated receptor-2 (PAR2) is a G-protein-
coupled receptor activated by serine proteases released from asthma-inducing pathogens as well
as by endogenous proteases associated with asthma inflammation. We have shown that PAR2
is a viable target for asthma drug development by identifyin two small molecule PAR2 antagonists,
C391 and C781, that limit allergen-induced asthma indicators following direct nasal application in
pre-clinical animal models. In this application we propose to characterize two novel PAR2
antagonists (C937 and C938) with improved pharmacodynamics and pharmacokinetics that could
allow for novel PAR2-directed antagonism treatment following oral drug administration.
Successful completion of the proposed feasibility studies (Phase I) will establish a novel drug lead
for asthma and allow for development of a small business Phase 2 application that will include
drug optimization and formulation, in vivo efficacy of lead compounds in allergen challenges of
chronic exposure mouse models as well as larger animal asthma models (rats and dogs) and
advanced in vivo PK studies. Our overall goal is to move these drug leads forward so that they
can be tested (Clinical Phase I studies) and used in humans to control asthma.

Public health relevance
PROJECT NARRATIVE: The objective of this Phase I feasabilty study is to develop a protease activated receptor-2 small molecule antagonist that can reduce/eliminate allergen-induced inflammatory effects in the lung. Through collaborations between our company, PARMedics, and the University of Arizona, we plan to develop a new class of therapeutics for asthma and other inflammatory lung diseases.